Machine Learning and Personalized Prognosis for Depression Treatment

Abstract Depression treatment is effective for approximately 50-60% of patients who receive treatment, but the probability of a successful response is typically unknown before treatment begins. As a result, depression treatment is routinely delivered in a trial-and-error fashion until a satisfactory response is achieved. Our objective is to provide a personalized prognosis by applying ensemble machine learning techniques to discover novel, non-linear combinations of multiple weak predictors that collectively yield accurate predictions of treatment outcome. This statistical approach considers many prediction variables simultaneously and iteratively constructs a complex prediction model that often dramatically outperforms traditional statistical methods. Aim 1 is to apply stochastic gradient boosted decision trees to predict response to citalopram using archival data from the STAR*D clinical trial. In preliminary analyses, we randomly selected 1223 patients to train the model and another 407 patients to independently test the model (a 75-25 split), with tuning parameters selected by cross-validation to minimize log-loss. The resulting prediction on the independent test sample was superior to the no-information rate (p < 0.001), with an overall predictive accuracy of 66%. Although this level of prediction is significantly better than a no information model, we plan to improve the model's prognostication by 1) adding features that capture the “pharmacological noise” of concurrent (non- study) medication use and 2) updating model predictions based on early signs of response. Aim 2 is to use a similar machine learning approach to examine response to internet-based CBT for depression. Internet-based treatments for depression are growing in popularity, provide efficient access to health care, reduce treatment costs, and have good evidence for treatment efficacy. Importantly, we have a large dataset (N = 1,013) within which to develop treatment-matching algorithms that predict treatment response based on patient attributes. Study Impact: The overarching goal of this project is to use machine learning methods to develop treatment matching algorithms. In the long term, we can envision a system that evaluates a patient on a number of important predictor variables and provides a personalized probability of treatment success. These probabilities would then be used to guide treatment selection or modify current treatment if a poor response is predicted. Developing algorithms that successfully predict whether a particular form of treatment is likely to be successful for a patient with a given set of attributes would be a tremendous step towards efficient and personalized depression treatment.

Public health relevance
Public Health Narrative Depression treatment is effective for roughly half of the patients who receive treatment, but it is usually unknown how a specific patient with a particular set of attributes will respond to a given treatment. Our objective is to provide a personalized prognosis by applying ensemble machine learning techniques to discover novel combinations of multiple weak predictors that collectively yield accurate predictions of treatment outcome. Developing algorithms that successfully predict whether a particular form of treatment is likely to be successful for a patient would be a tremendous step towards efficient and personalized depression treatment.